Exploiting the Ref-1 node in pancreatic cancer: tailoring new pancreatic cancer therapy using multi-targeted combinations

Pancreatic ductal adenocarcinoma or PDAC is a lethal disease with a 5 year mortality rate of ~93% and little
improvement has been made despite the emergence of several targeted, selective agents. Therefore, a new
approach is needed. We will pursue transcriptomic-guided combination therapy as well as targets that are
upstream of several signaling pathways, thereby affecting multiple downstream cellular processes and potential
resistance mechanisms. Redox factor-1 (Ref-1) is one such protein, as Ref-1 regulates multiple transcriptional
factors (TFs) that are critical to pancreatic cancer survival and drug resistance. In the previous funding period,
we have advanced APX3330, a Ref-1 inhibitor and the first drug targeting Ref-1 to cancer clinical trials (IND
125360) as a novel, oral, first-in-class drug in humans. We have shown that APX3330 reduces tumor growth
in several models of PDAC as a single agent and potentiates gemcitabine-mediated inhibition of cell growth. The
mechanism of action of APX3330 has been extensively investigated and characterized by our team. Through
inhibition of Ref-1, the activity of STAT3, AP-1, NFkB, and HIF-1 can be blocked leading to a decrease in
survival protein expression and response to hypoxia. Recognizing that combination therapy will be necessary in
PDAC, we propose to utilize transcriptomic data to identify FDA-approved agents that are likely to synergize with
APX3330. Drug synthetic lethality is defined as combination therapy of molecular targets whose dual inhibition
leads to potentiation of cell death much more dramatically than when administered as single agents. Single cell
RNA-seq data identified HIF-1 signaling pathways as significantly down-regulated following Ref-1 knockdown
(p=0.0008). Therefore, we tested the combination of Ref-1 inhibition and HIF-1 target, carbonic anhydrase (CA9)
in our 3-Dimensional (3D) tumor co-culture model. Dramatic enhancement of Ref-1-induced cell killing is
observed upon dual-targeting of Ref-1 and CA9. Our hypothesis is that in order to extend the survival of PDAC
patients multi-targeted, combination therapy is essential; therefore we will use original, pathway-driven
screening approaches to discover appropriate FDA approved agents to partner with our Ref-1 inhibitor. AIM 1-
Evaluate the mechanism and efficacy of simultaneous inhibition of the Ref-1 and HIF-1 pathways using in vivo
models of PDAC. AIM 2- Investigate the role of Ref-1 in sensitizing PDAC to chemotherapy currently used in
PDAC treatment. Gemcitabine (Gem), one of the agents that single cell RNA-seq expression profiling predicted
should work with APX3330, will be used in combination with APX3330 in the phase 1B trial. AIM 3- Screen for
drug synthetic lethal hits following Ref-1 inhibition in a validated 3D model system utilizing computational and
transcriptomics pathway analysis. Selective disruption of individual molecular effectors has clear limitations; our
approach focuses on multi-targeted combination treatments. Thus, this project has the potential to extend
pancreatic cancer survival by using appropriate disease-relevant models such as 3D co-culture spheroids,
orthotopic, and GEM models.

Public health relevance
This project has high clinical / translational value as it seeks to discover an effective combination therapy based on transcriptomics, a computational pipeline that will predict which agents will induce synthetic lethality, and sophisticated in vitro and in vivo model systems. We will also study the mechanism behind the synergy using state-of-the-art disease-relevant models including 3-dimensional tumor spheroids in co-culture with cancer- associated fibroblasts (CAFs), orthotopic, and genetic GEM models.